A Multisite Randomized Trial of BattleViro: A Mobile Gaming App to Improve ART Adherence for Youth

Despite need for consistent adherence to medical care, youth living with HIV (YLWH) have low rates of
adherence and retention in care, and are at great risk for being lost to follow-up.(5,16-18) There is a great
need for adherence interventions that are novel and appealing for YLWH.(7,8,14) We developed, and
preliminarily examined, a multi-level technology that integrates a 7-day smart medication device (Wisepill)
WITH an immersive and appealing smartphone app/game that is attractive and engaging for YLWH.(82,83)
During gameplay, YLWH fight HIV in colorful and immersive organ systems, and receive adherence related
text messages with game graphics. Wisepill openings guide game-related text messages and can result in
bonus points in the app/game. We tested the Multilevel Gaming Intervention in a developmental trial. The
impact of the intervention was greatest among those who had newly begun ART. In participants who had newly
begun ART, the intervention decreased viral load and improved ART adherence. Those newly starting ART in
the intervention, compared to those newly starting ART in the control, experienced a 0.96 log viral load greater
decrease and evidenced a large effect size for improved adherence as measured by Wisepill (d=1.18, 71% vs.
48% adherence at post-test). These interactions between intervention and newly starting ART were significant
in ANCOVAs, accounting for baseline values (viral load: F=4.33, p=0.04, adherence: F=3.20, p=0.05). For this
next proposed stage of research, we will further test the Multilevel Gaming Intervention with YLWH who are
newly starting ART at clinical sites in New England and in Mississippi. A multisite randomized controlled study
(48 weeks) among 120 YLWH newly starting ART will test the efficacy of the intervention compared to a control
condition (who receive a non-HIV game and the Wisepill) on behavioral and biological measures.
Information, Motivation,
Behavioral Skills
Adherence to ART
Immersive iPhone
Electronic, portable, 7-day medication
game with text
organizer/dispenser: measures adherence
messaging
integrates into iPhone gameHIV RNA Viral Load

Public health relevance
Project Narrative Despite the need for consistent adherence to medical care, youth living with HIV have low rates of adherence to medications and treatment. We developed a mobile app/gaming intervention that is integrated with a 7-day electronic medication device (Wisepill) and found that the game improved adherence and decreased HIV virus (viral load) among youth newly starting ART. This proposed project will test the intervention with a larger number of youth who are newly starting HIV treatment and medications in New England and in Mississippi.